Understanding the OAS/RNase L pathway during pathogenic viral infections

PROJECT SUMMARY
Ribonuclease L (RNase L) is a key component of the mammalian innate antiviral response. For decades, RNase
L was presumed to reduce viral protein synthesis by cleaving ribosomes to arrest translation. However, we and others
recently demonstrated that RNase L-cleaved ribosomes are translation-competent, and that pathogenic viruses can
synthesize proteins despite activating RNase L. These observations have revealed a significant gap in knowledge
regarding how RNase L functions and how viruses evade it. We have demonstrated that RNase L rapidly degrades nearly
all cellular mRNAs upon activation. This activity regulates three cellular processes that have expanded our understanding
of RNase L and that have elucidated how pathogenic viruses evade and potentially hijack RNase L functions. First,
RNase L reprograms translation to an antiviral state by degrading constitutively expressed cellular mRNAs while
sparing host mRNAs encoding antiviral proteins (e.g., type I interferons), which permits antiviral protein synthesis.
Importantly, the mRNAs encoded by several pathogenic viruses (e.g., dengue virus) similarly evade RNase L-mediated
mRNA decay, thus permitting viral protein synthesis. This observation has elucidated how pathogenic viruses synthesize
proteins despite activating RNase L. This application proposes to characterize the RNase L-mediated mRNA decay
pathway and determine how host and viral mRNAs evade it. Second, RNase L activation triggers the inhibition of nuclear
mRNA export. This is a critical antiviral mechanism that antagonizes influenza A virus protein synthesis, but it also
downregulates the expression of host antiviral proteins (e.g., type I interferons). Importantly, pathogenic viruses (e.g.,
dengue virus) activate this RNase L-dependent pathway, resulting in sequestration of host antiviral mRNAs in the
nucleus. This observation suggests that viruses potentially hijack this function of RNase L to limit host antiviral protein
production. This application aims to determine how RNase L inhibits mRNA export, the breadth of viruses it antagonizes,
how it impacts host antiviral gene expression during pathogenic viral infections. Third, RNase L regulates the assembly
of cytoplasmic antiviral ribonucleoprotein complexes. Specifically, RNase L inhibits the assembly of stress granules and
promotes the assembly of an alternative stress granule-like ribonucleoprotein complex termed RNase L-dependent body.
RNase L-dependent bodies are the predominant antiviral granule assembled in response to SARS-CoV-2 or dengue virus
infection, yet their function is completely unknown. This application aims to determine the function of antiviral stress
granules and RNase L-dependent bodies and to determine how their regulation by RNase L alters the antiviral response.
Understanding the mechanisms and functions of these cellular processes will advance our understanding of the
OAS/RNase L pathway, innate immune antiviral gene induction, and virology. Moreover, it will promote general
medicine by broadly characterizing fundamental cellular, molecular, and RNA biology that is relevant to non-infectious
diseases, including autoimmune diseases, neurodegeneration, and cancer. Lastly, the proposed research will support the
development of promising antiviral, immunomodulatory, and anticancer therapies based on RNase L biology.

Public health relevance
PROJECT NARRATIVE Ribonuclease L (RNase L) is critical for combatting viral infection, yet how it functions remains elusive. The research proposed in this application will define the mechanisms and functions by which RNase L accelerates mRNA decay, reprograms translation, inhibits nuclear mRNA export, and regulates the assembly of innate immune ribonucleoprotein complexes. It will also examine how pathogenic viruses evade and potentially hijack the OAS/RNase L antiviral pathway for their own benefit.